MODELLING TH1 &TH2 SYSTEM MATH MODELLING OF IMMUNOLOGICAL REACTIONS: HIV

A set of ordinary coupled, time delay, linear differential equations are used to describe the interaction of two kinds of T-cells (Th1 and Th2), with four kind of interleukin (Il2, Il4, Il10, Interferon). The cells are described by distributions of recepter densities. The goal of the work is to make biometric estimations by comparisons with experimental data.